Treatment of post-infarction cardiac remodeling using image-guided delivery of microRNA-loaded microbubbles and ultrasound-mediated cavitation

Adverse left ventricular (LV) remodeling is a severe and common complication of acute myocardial infarction
(AMI). It is characterized by acute infarct thinning and dilation, followed by chronic LV dilation, hypertrophy, and
excess fibrosis in both infarct and remote non-infarct regions. This leads to globally reduced LV systolic function,
heart failure (HF), frequent hospitalization, and death. Beyond daily agony from symptoms of ischemic HF, the
financial burden is high, particularly since HF prevalence (~26 million worldwide) is rising as the population ages.
Unfortunately, current drugs for remodeling merely delay progression and do not treat root causes. Thus, there
is a vital, unmet need for treatments targeting newly identified pathways that cause post-AMI remodeling.
MicroRNAs (miRs) are endogenous short RNAs that regulate normal gene expression by binding to target
messenger RNAs (mRNAs), causing mRNA degradation or repression of mRNA translation into its target
protein. However, miRs can be abnormally expressed in adverse remodeling. For example, miR-92a increases
during AMI, suppressing specific mRNAs encoding for cardioprotective proteins. miR-92a has been causally
implicated in adverse remodeling. Excitingly, miR-92a inhibition by antimiR-92a, an oligonucleotide (oligo) which
binds to and inactivates miR-92a, attenuates remodeling in pre-clinical AMI models. However, antimiR-92a
therapy is currently clinically unfeasible: Systemic delivery has poor efficacy and requires high doses,
resulting in unwanted delivery to extra-cardiac organs and high cost. To advance clinical translation of antimiR-
92a therapy, we developed ultrasound-targeted microbubble cavitation (UTMC), a theranostic ultrasound-based
approach for focal delivery of antimiR-92a. This comprises intravenous injection of antimiR-92a-loaded
microbubbles (MBs) which expand and contract (cavitate) as they transit the coronary microcirculation in the
presence of ultrasound (US) aimed at the heart. US imaging spatially guides delivery, and MB cavitation releases
and concentrates payload in insonified heart by causing cell membrane pores and endothelial hyperpermeability.
We have optimized MB and acoustic parameters for UTMC; proved UTMC oligo delivery to hypertensive murine
heart; and generated preliminary data in rats with AMI suggesting superior efficacy and cardiac targeting of
UTMC antimiR-92a delivery positioning UTMC for clinical translation. We hypothesize that UTMC-mediated
cardiac antimiR-92a delivery will prevent adverse remodeling post-AMI and propose critical next steps for
clinical translation: We will use a rat AMI model to define optimal antimiR-92a dose (Aim 1), then test UTMC
cardiac antimiR-92a delivery for preventing remodeling in a clinically relevant porcine AMI model (Aim 2).
Readouts will span whole organ function to gene expression and comprehensive safety and biodistribution
measurements. Our data will, for the first time, establish the clinical feasibility and safety of UTMC and form the
basis for future IND-enabling studies focused on clinical translation of UTMC-mediated cardiac delivery of
antimiR-92a to treat adverse LV remodeling ultimately reducing suffering and death from HF post-AMI.

Public health relevance
PROJECT NARRATIVE After acute myocardial infarction (AMI), adverse ventricular remodeling — acute thinning and dilatation of the infarcted heart muscle, followed by progressive hypertrophy, dilatation, and fibrosis of the non-infarcted heart muscle — frequently leads to heart failure (HF) and death. Current therapies are limited and do not address root causes. A promising new treatment is to deliver oligonucleotides (oligo) to inhibit activity of microRNA-92a, a short nucleotide sequence that binds to target messenger RNA, suppressing synthesis of cardioprotective proteins in the setting of AMI. Unfortunately, clinical application of this approach is stymied by a lack of efficient, safe, cardiac-specific oligo delivery strategies. To address this hurdle and foster clinical translation, we will use a novel theranostic method, ultrasound targeted microbubble cavitation (UTMC), for cardiac delivery of an oligo inhibitor of microRNA-92a. Using clinically relevant animal models of AMI, our principal aim is to advance clinical translation of UTMC for delivery of therapeutic RNAs to reduce adverse ventricular remodeling after AMI.